Using Real-Time Methods to Investigate Emotion Regulation as a Modifiable Target Connecting Adolescent Social Media Use and Mood

PROJECT SUMMARY/ABSTRACT
Adolescent social media (SM) use is linked to adverse mental health outcomes (e.g., depression, anxiety,
suicidal thoughts/behaviors) for some adolescents but not others. Adolescent rates of depression and suicidal
thoughts and behaviors are steadily rising. In 2021, 42% of high school students reported persistent feelings of
depression and hopelessness, and 10% attempted suicide. As SM may contribute to these staggering numbers,
it is crucial to understand what separates positive from negative SM mental health outcomes among adolescent
SM users.
Emotion regulation is a modifiable factor and widely used clinical intervention target that may amplify or
buffer against negative mental health outcomes resulting from adolescent SM use. For example, if an adolescent
has a negative experience on SM, if they choose an adaptive emotion regulation strategy (e.g., reappraisal),
they may decrease negative mood and ultimately not experience mental health consequences. On the other
hand, if they repeatedly choose maladaptive strategies (e.g., avoidance, rumination), they could amplify their
negative mood, increasing risk for developing mental health concerns (e.g., depression, suicidal
thoughts/behaviors).
To inform future intervention work targeting emotion regulation to maximize adolescent SM and mental
health outcomes, this NRSA proposes to identify: 1) How adolescents regulate their emotions following negative
SM experiences, 2) Which emotion regulation strategies amplify or buffer against negative mood following a
negative SM experience, and 3) The specificity of these relationships to SM relative to other social contexts.
This study will recruit 50 adolescents (age 14-17; grades 9-12). Participants will complete ecological momentary
assessment (EMA) prompts 3x/day over the course of four weeks to measure 1) negative SM experiences, 2)
emotion regulation strategy selection following each experience, and 3) mood. Passive smartphone sensing will
additionally capture SM use behaviors. This study will build upon and extend the sponsor (Dr. Hamilton)’s K01
study (K01MH121584).
Using this high-dimensional data, multilevel models will evaluate which emotion regulation strategies
adolescents most commonly use following a negative SM experience, differential effectiveness of these emotion
regulation strategies, and the specificity of these effects to SM relative to in-person social contexts.
The immediate impact of this study will be to identify whether emotion regulation strategies have the potential to
modify mood following a negative SM experience. More broadly, this study will inform clinical interventions
targeting emotion regulation—a core element of many existing evidence-based treatments—to buffer against
possible negative mental health effects of adolescent SM use.

Public health relevance
PROJECT NARRATIVE Adolescent mental health has been named a public health emergency, with rates of depression and suicide rising steadily. Social media (SM) is linked to negative mental health consequences for some adolescents but not others, and no studies to date have uncovered a modifiable target that could alter the course of negative mental health outcomes for affected adolescents. This NRSA project proposes to identify whether emotion regulation strategies—a widely used and effective target in existing clinical interventions—may contribute to these differential patterns and may be a candidate target for future adolescent SM/mental health interventions.